Defining Antigen-Dependent and Antigen-Independent Mechanisms for EGFRviii-Expressing Tumor Escape From Therapy

PROJECT SUMMARY/ABSTRACT
Glioma is a form of cancer that occurs in glial cells in the brain and central nervous system. Glioma has very
poor prognoses in children and adults due to lack of, or ineffective, available therapies. Commonly used available
therapies for gliomas and other brain cancers include surgery, radiation therapy, and chemotherapy. However,
these therapies only prolong survival and rarely completely eliminate the tumor. One potential therapy for glioma
that has been tested in clinical trials is CAR T cell therapy targeting epidermal growth factor variant 3 (EGFRviii).
Similar CAR T cell therapies have proven effective and are approved in blood cancers, including diffuse large B-
cell lymphoma (DLBCL), acute lymphoblastic leukemia (ALL), and multiple myeloma. However, CAR T cells
have proven less effective in glioma and other solid tumors and certain tumor cells ‘escape’ from CAR T cell
therapy, and develop resistance to CAR T cells. Potential tumor cell intrinsic factors that may lead to escape
include lack of homogeneous antigen expression, mutations in the EGFRviii target antigen itself, and mutations
in other genes leading to resistance to killing. In this grant, I propose to study genomic and transcriptomic
mechanisms for tumors that escape from CAR T cell therapy, and hypothesize that tumors that escape from
CAR T therapy acquire distinct targetable mutational loads through the activation of APOBEC cytidine
deaminase enzymes. I propose to generate tumors that escape from and develop resistance to sub-optimal T
cell therapies both in vivo and in vitro, and characterize the mutational load and transcriptional changes that
occur upon escape from CAR therapy. Depending on genomic and transcriptomic changes that occur, I will
propose and test either a chemotherapeutic combination targeting mutational pathways such as APOBEC, or an
immunotherapeutic combination therapy targeting neoepitopes in mice. If successful, the overall impact of this
research will be the identification of mutations and changes in gene expression that are the result of CAR T cell
therapy in escaped variants, and a potential combination therapy to target CAR escaped variants.

Public health relevance
PROJECT NARRATIVE Solid and blood tumors are known to escape from and develop resistance to therapies, which renders therapies ineffective and leads to tumor progression. In this project, I propose to determine the mechanism of glioma escape from epidermal growth factor variant three (EGFRviii) targeted chimeric antigen receptor (CAR) T cell therapy and to design and test novel combination therapy strategies to prevent escape from and resistance to CAR T cells. The goal of this project is to provide better combination therapy strategies for use in patients based on mutations observed in tumor escaped cells in patients with glioma and other solid tumors.